Transgenic Mouse Shared Resource

TRANSGENIC MOUSE SHARED RESOURCE ABSTRACT
The availability of the Transgenic Mouse Shared Resource (TMSR) enables our investigators at the Moores
Cancer Center (MCC) to conduct versatile, cutting-edge research with a battery of sophisticated genetic
techniques for manipulation of the mouse genome to create models for studies of cancer for incisive in vivo
mechanistic investigations of the fundamental processes involved in the etiology of tumor development and
metastasis. Transgenic mice carrying new or novel genes are created by microinjection of DNA into the
pronuclei of fertilized eggs, specific deletions and mutations are created using CRISPR/Cas9 technology, and
“knock-out” mice that have deleted or modified genes of interest are created by homologous recombination in
embryonic stem cells followed by injection into blastocysts to create chimeric mice for breeding to
homozygosity. The high degree of conservation of most sequences in genomes of humans and mice makes
using mouse genetic manipulation technology to create models of human cancer pathogenesis extremely
useful. These approaches are remarkably powerful in cancer research, particularly in the analysis of
oncogenes, metastasis, cell-cycle control, tumor suppressor genes, and in the crafting of cancer model
systems for developing new treatment regimens, and methods for drug testing and tumor imaging. The mission
of this Shared Resource is to provide the highly technical aspects of manipulation of genes in embryos and
mouse embryonic stem cells as a service to MCC members, to create the genetically manipulated mouse
models they need. This is an example of how specialized techniques, highly trained and dedicated personnel,
and expensive equipment can be accessed by researchers who could not reasonably expect to develop or
obtain them on an individual basis. The TMSR provides cutting-edge, rapidly advancing, efficient, cost-effective
services that adapt to the needs of our users, drive the field of mouse genetics, and continue to be very
responsive to the vast creativity of the CCSG membership, fulfilling their needs for the most cutting-edge
embryology and molecular genetics in the mouse.